Natural history, pathogenesis, and treatment of alopecia

The goal of this project is to systematically evaluate cohorts of alopecia (hair loss) patients to study the natural history of defined forms of alopecia. We will use clinical and translational (gene expression, immunology, microbiome, and genetics) approaches to expand our understanding of the pathogenesis of alopecia and the factors that contribute to the different clinical phenotypes. Additionally, we will study patients as they undergo treatment for their alopecia to understand therapeutic responses. The ultimate goal will be to improve treatment outcomes for patients with alopecia.